NIA IRP Comparative Medicine Section

The CMS supports the research of NIA scientists. A critical focus of this support is training in the humane care and handling of research animals. CMS is responsible for housing and care of research animals and for enhancing their well-being. The animal program and animal laboratory areas are inspected and evaluated at least twice each year by the NIA Animal Care and Use Committee (ACUC), in compliance with federal regulations and guidelines.[unreadable] [unreadable] The training offered through NIA CMS ensures that all animal handling is in compliance with NIA, NIH, and federal regulations and guidelines for the continued assurance of full accreditation by the AAALAC, International. The NIA CMS also develops and/or recommends refinements in humane care and handling and provides training to NIA intramural researchers.[unreadable] [unreadable] All NIA research staff using animals is required to complete facility-specific training. This training includes requirements for facility entry, proper animal handling procedures, and other related issues. The NIA APD and ACUC Chairperson also provide updates on new/revised Federal, NIH, and/or NIA animal welfare guidelines at monthly NIA meetings.